Wireless Implantable Mechano-Acoustic Recording Device

PROJECT SUMMARY - ABSTRACT
We will design a fully implantable, wireless, battery-free, Mechano-Acoustic (MA) device that allows for multi-
parameter physiological data acquisition from freely moving small animal models, via use of high bandwidth
triaxial accelerometers. The proposed technology records relevant vital sign information such as the heart and
respiration rate and temperature, and other general features about the animal that include locomotion and body
orientation. Each of these features are determined in parallel from subtle motions detected with this platform
using the most advanced inertial measurement unit (IMU) technology and transmitted wirelessly and analyzed
in real-time using Bluetooth Low Energy (BLE) 5.2 to an external reader system – all isolated to individual
subjects within experimental contexts spanning single to multi-animal behaviors. This approach allows other
experimental approaches (video tracking, neural recording, closed-loop optogenetics, etc.) to be directly coupled
to the recorded physiological data. Integration of a BLE 5.2 reading board into the existing NeuroLux Power
Distribution Control (PDC) box will enable simultaneous use with other devices in NeuroLux’s product portfolio,
including fully implantable optogenetic devices and wireless drug-delivery systems that are currently in
widespread use across various parts of the neuroscience community. By delivering both power and data
wirelessly, and by entirely eliminating all external fixtures and physical tethers on the animal, the proposed
technology enables chronic physiological recordings in three-dimensional naturalistic environments, from
isolated individuals or social groups, in ways that are fundamentally impossible with conventional hardware
infrastructure. This low-cost manufacturable system is fully compatible with the NeuroLux radio frequency
wireless electronic platform and control software, allowing us to leverage the strengths of an existing commercial
platform currently in use in >150 laboratories worldwide to further advance neuroscience research capabilities.

Public health relevance
PROJECT NARRATIVE The proposed program focuses on the development of a fully implantable, battery-free device for wireless data acquisition of physiological data including heart and respiratory rate, temperature, and other behavioral information such as locomotion and orientation of rats and mice. This novel technology, which is fully compatible with the NeuroLux radio frequency wireless electronic platform, represents an important advanced tool for experimental behavior research that enables non-tethered, non-invasive operation in cages with simple or complex environments in individual or groups of animals.